Maximizing Investigators' Research Award (R35 - Clinical Trial Optional)

PROJECT SUMMARY:
The evolutionarily conserved Wnt pathway plays a critical role during metazoan development
and stem cell maintenance in the adult. Mutations in the Wnt pathway leading to its
misregulation in humans have been shown to contributes to both developmental defects and
cancers. In the latter case, over 90% of all non-hereditary forms of colorectal cancers are
initiated by mutations in the Wnt pathway leading to its inappropriate activation. There are no
FDA-approved drugs that inhibit the Wnt pathway, which is likely due to our incomplete
understanding of the mechanism of Wnt signaling and the lack of suitable drug targets. The
primary focus of my lab is to understand the biological function of the Wnt signaling pathway by
deciphering its molecular mechanism and identifying new Wnt components. Our ultimate goal is
to use this information to understand how deregulation of the Wnt pathway can lead to Wnt-
driven diseases in humans.
Over more than a decade, my lab has made significant contributions to our fundamental
understanding of Wnt signaling. These breakthroughs were accomplished via the development
of the first biochemical system (using Xenopus egg extract), the reconstitution of active purified
proteins, the development of the first mathematical model (Lee-Heinrich model), and the
identification of small molecule inhibitors (CK1 agonists), one of which has been designated by
the FDA as an orphan drug for a familial precancerous disease (familial adenomatous
polyposis).
Our current work focused on determining the role of the USP46/UAF1/WDR20 deubiquitinase
complex in regulating LRP6 receptor turnover, the mechanism by which APC regulates Wnt
receptor activity, the role of the -catenin degradation complex in mediating bistable pathway
behavior, and the roles of USP47 and STK38, in regulating Wnt signaling. In our renewal
application, we now propose to 1) reconstitute LRP6 ubiquitylation and identify its evolutionarily
conserved E3 ligase, 2) understand the basis for signal compensation upon Wnt receptor loss in
APC mutant cells, 3) provide evidence for the role of bistability in generating morphogenetic
signaling, and 4) uncover the roles of the STK38 and TRIP12 in nuclear Wnt signaling.

Public health relevance
NARRATIVE: This proposal focuses on the mechanism of Wnt signal transduction, which plays an essential role in embryonic development and in adult stem cell maintenance. Our current work focuses on control of Wnt coreceptor stability by the USP46 complex, the role of the tumor suppressor, APC, in regulating Wnt receptor activation, the establishment of bistable behavior by the - catenin destruction complex, and the regulation of Wnt-mediated transcription by the proteins, USP47 and STK38. We now propose to reconstitute LRP6 ubiquitylation, uncover compensation mechanisms that activate signaling in APC mutant cells, determine the contribution of APC in Wnt pathway bistability, and characterize the role of a newly identified component of the Wnt pathway, TRIP12.